Colorado Clinical and Translational Sciences Institute (CCTSI)

Instruction: Funded by NIH since 2008, the Colorado Clinical and Translational Sciences Institute (CCTSI) at the University of Colorado Denver (CU Denver) has transformed the clinical and translational research and training enterprise in the Colorado region with the vision of accelerating the translation of discoveries into improved patient care and public health for all. The CCTSI, headquartered at the CU Anschutz Medical Campus, is a partnership of CU Denver, CU Boulder, Colorado State University (CSU), 5 hospital systems and 20 community organizations, which has advanced translational science by educating a successful workforce, creating a collaborative environment that supports local and multi-site research, engaging Colorado communities through its unique community engagement program, and greatly enhancing our informatics and data science capabilities. Despite the successes, there remain many challenges to overcoming inefficiencies and roadblocks in clinical translational science (CTS) processes locally and nationally. This application maps our collaborative path forward to meet these challenges. In the next grant cycle, we will enhance our efforts to improve efficiency and coordination with Partners and across the CTSA Consortium, reinforce our extensive community partnerships, develop innovative informatics and technology solutions to advance CTS, and develop a highly skilled translational workforce for the future. This UM1 will be tightly coordinated with our other 6 CTSA grant applications, to accomplish the following 6 Overall Strategic Goals: Goal 1: Advance CTS by developing, demonstrating, and disseminating innovative programs to improve the efficiency and impact of translation across the entire T0.5 to T4 spectrum. Goal 2: Promote collaboration, team and data science, and partnerships to accelerate CTR locally, regionally and nationally. Goal 3: Partner locally, regionally and nationally with institutions, stakeholders and communities to develop innovative research programs that will address the nation’s most pressing health issues. Goal 4: Further develop operational efficiencies to enhance the quality, safety, efficiency, effectiveness and informativeness of clinical research. Goal 5: Promote a nimble research environment that can rapidly respond to urgent public health needs. Goal 6: Develop and disseminate CTS training programs that educate and sustain a resilient clinical research professional workforce. Progress will be monitored and improved by our Evaluation Core and Continuous Quality Improvement program and we will make mid-course corrections as needed to achieve these goals and ultimately improve the health of our state and the nation.

Public health relevance
Instruction: The Colorado Clinical and Translational Sciences Institute (CCTSI) is a Partnership among University of Colorado Denver’s two campuses, University of Colorado Boulder, Colorado State University, five hospitals and multiple community organizations committed to translating discoveries into improved public health and patient care for all. Through innovative programs and collaborations to advance clinical and translational science, the CCTSI will facilitate the performance of high impact research and the training of the next generation of clinical-translational researchers. Advancing team and data science, and being poised to respond to a public health emergency will be emphasized and ongoing evaluation and quality improvement will assure maximum efficiency and impact of our programs.